Core G: Neuroimaging Core

ABSTRACT – CORE G: NEUROIMAGING CORE
The overall objectives of the Neuroimaging Core (NIC) are to provide and integrate state-of-the-art,
standardized MRI and PET imaging measures for Michigan Alzheimer’s Disease Research Center (MADRC)
participants, work with both internal and external stakeholders to evaluate and deploy novel imaging
biomarkers, and engage in collaborations, consultation and educational efforts to maximize the utility of these
measures. The NIC will acquire longitudinal structural and functional MRI on all eligible MADRC participants
using consistent imaging devices and providing flexible scheduling to assist in recruiting non-local participants.
The NIC will also provide access to tau and amyloid PET protocols and quantitation. The NIC will provide
standardized image processing (e.g. morphometry, connectivity, lesion measures) and, in coordination with the
Data Management and Statistical Core (DMSC), maintain an internal archive of imaging data that can be
accessed by all MADRC researchers. The NIC will also study and validate novel imaging biomarkers using
MRI, including myelin-water fraction (MWF), iron accumulation using quantitative susceptibility mapping,
microstructural modeling using diffusion MRI, hippocampus subfield volumetry, and vascular pathology. The
NIC will collaborate with the Clinical Core to coordinate and facilitate imaging of MADRC participants, and work
with the DMSC to provide access to imaging data locally and nationally, including summary measures from
neuroimaging data, and collaborate with the Biomarker Core on biomarker validation. The NIC will consult with
new and existing investigators on the design of neuroimaging studies, making use of standardized imaging
protocols whenever possible. We will also provide consultation on novel imaging biomarkers as they are
deployed. Finally, we will work with the Research Education Component to provide didactic and hands-on
training related to MRI and PET acquisition and analyses. Through these efforts, the NIC will provide high
quality non-invasive neuroimaging data to facilitate early diagnosis, prediction, and monitoring of disease
progression, providing a rich source of data beyond traditional clinical markers.